Dev-Core-001

DEVELOPMENT CORE: PROJECT SUMMARY
The key mission of the Development Core is to advance innovative population dynamics research and support
early career investigators. The primary activities under this Core include a pilot grant program offering
competitive funding for high-risk, high-reward research; a weekly seminar series; an array of workshops,
colloquia, and events, all aimed at fostering new research endeavors and collaborations across the Center’s
research priority areas; and regular trainings and talks oriented around grant-writing and data-use. The
Development Core implements and infuses innovative population science by supporting and mentoring early-
stage scientists at each step of their career, and by capitalizing on the resources and services from the
administrative core to create a cohesive, vibrant community through which affiliates can conduct the highest
caliber population science. The Core also provides significant pilot grant resources along with thorough
feedback for all grant proposals from start to finish throughout the submission process. This Core’s resources
are available to both BPC affiliates who are UC Berkeley faculty as well as External Scholars at northern
California institutions not otherwise supported by an NICHD P2C population research infrastructure grant.